Graduate Training in Molecular Biology and Biophysics

DESCRIPTION (provided by applicant): Continued support is requested for an ongoing program of graduate research training in molecular biology and biophysics at the University of Oregon. This training activity is centered in the Institute of Molecular Biology, and also involves additional groups with related scientific interests. Funds are requested for 12 predoctoral positions, within a program that includes approximately 50 graduate students, 46 postdoctoral trainees, and 19 training faculty. The program places special emphasis on the control of gene expression and nucleic acid structure/function, molecular basis of signaling and cell function, protein structure and dynamics, and molecular approaches to development and differentiation. The basic aspect of the training is laboratory research carried out under the direction of a faculty member in the molecular biology and biophysics training program. Through this experience, the trainee becomes skilled at posing questions about fundamental biological processes and designing experiments to answer those questions. The training is augmented by formal courses offered by the Biology, Chemistry, and Physics Departments, by seminar programs that highlight current research in molecular biology, biophysics, and related disciplines, by the close involvement of a Thesis Advisory Committee, and by research seminar and journal club presentations by trainees. The training facilities include the laboratories of the faculty and support services such as the structural biology facility, the state of the art genomics and proteomics facilities, biophysical chemistry equipment facility, the media preparation facility, an electron, confocal and 2-photon microscope facility, and a polyclonal/monoclonal antibody facility. Major equipment is shared and housed in common space. The laboratories of most of the faculty are contiguous and in interconnected buildings. This arrangement fosters interactions and collaborations among faculty and students.